Gene and Chromatin Analysis Core

PROJECT SUMMARY/ABSTRACT– GENE AND CHROMATIN ANALYSIS CORE
The Gene and Chromatin Analysis Core provides the technical and bioinformatics infrastructure to
optimally mine the large amount of genome-wide gene expression and chromatin data that are generated from
the PPG’s work. PPG investigators lead the field in several aspects of genome-wide analyses, including
pioneering these approaches to specific cell types in brain, which offers several technical challenges. We have
optimized methods for several next generation sequencing approaches, including RNA-seq, ChIP-seq, ATAC-
seq, HiC, and whole genome bisulfite sequencing, among others, for rodent and human brain, the latter
offering an additional set of unique technical challenges. These approaches are being used increasingly to
study individual cell types within a given brain reward region, in both rodent and human. The Core has
established expertise in analyzing the highly complex datasets obtained, and will work on further improving the
tools available. All of the genome-wide data generated by our PPG are analyzed by this Core. In parallel, the
Core runs routine genome-wide assays on defined animal models, with the Animal Models Core, and thereby
provides a foundation for the more specific and sophisticated measures in the individual Projects. Indeed, each
Project focuses on genes that are among the most robustly regulated across rodent addiction models and
human substance use disorders. As well, the Core pilots novel experimental technologies; an example is our
ability to target single chromatin modifications to a single gene within a single brain region and cell type in vivo,
thus providing an unparalleled level of proof to establish transcriptional mechanisms of addiction. By
consolidating the analytical work and routine genome-wide analyses within a centralized Core, we ensure
rigorous control over the data and facilitate comparisons of experimental findings across the four individual
Projects. This consolidation also makes financial sense, since we concentrate and maximize efficient use of
our expertise. Finally, the Core is responsible, with the Administrative Core, in maintaining a platform for
sharing our genome-wide datasets and analytical tools across the PPG’s laboratories as well as with the
scientific community and lay public at large.